Multimodal assessment of neural, neuroendocrine, and immune cue responses in binge drinkers in the laboratory and real world.

Abstract
Binge Drinking (BD) is a known risk factor for Alcohol Use Disorders (AUDs). Why some people
“mature out” of BD while others persist and develop AUDs may not only be related to the adoption of adult
social roles, but may also be due to one’s physiological response to BD. One mechanism contributing to BD
appears to be enhanced cue reactivity, i.e., greater craving and alcohol consumption in response to alcohol
associated stimuli. We have recently identified several components of a potential multi-attribute biomarker of
BD: mPFC activation to cues with concomitant, correlated lower cortisol, higher interleukin 6 (IL-6), and higher
craving responses to cues relative to social drinkers, all of which are related to immediate drinking in the
laboratory, and future drinking in the real world. The overall goal of this application is to examine
neurobiological factors (i.e., neural, neuroendocrine, and immune) associated with BD and cue-induced
drinking longitudinally, based on the premise that these neurobiological changes are associated with real
world processes that make individuals more vulnerable to drinking in response to alcohol cues in daily life over
micro (momentary) and macro (years) time intervals. We aim to replicate and extend our previous findings
demonstrating that associated dysregulations in neural, neuroendocrine, immune cue responses constitute a
multi-attribute biomarker of BD and are related to craving/drinking in the lab and real world in BD. We will also
examine the moderating effects of each individual neurobiological vulnerability (neural, neuroendocrine,
immune) and the composite risk propensity score on intraindividual associations between cue exposure in the
real world and craving/ drinking in daily life. Furthermore, we aim to characterize the relationships between
trajectories of change in individual neurobiological vulnerabilities, including the risk propensity score, with
trajectories of change in drinking behavior. Finally, we will examine the moderating effects of sex on the
relationship between drinking group membership and neurobiological vulnerabilities with 1) craving/drinking
behavior in the laboratory/ real world, 2) the relationship between cue exposure and craving/drinking, and 3)
trajectories of BD over 2 years. Successful completion of this project will provide evidence of neurobiological
vulnerabilities associated with BD and cue-induced drinking, which could serve as malleable intervention
targets prior to the onset of AUD.

Public health relevance
Project Narrative 30% of Americans ages 18-30 engage in binge drinking (BD); while one third of binge drinkers transition to healthier approaches to alcohol consumption in the next few years, roughly a third persist with binge drinking without developing an Alcohol Use Disorder (AUD), and another third develop an AUD. This project aims to elucidate the role of neurobiological risk factors in the trajectory of AUD development. Successful completion of this project will provide evidence of neurobiological vulnerabilities associated with BD, which could serve as malleable intervention targets prior to the onset of AUD.